Resolving Human Brain Activation Across Cerebral Cortical Layers with Line-Scan Functional MRI

PROJECT SUMMARY/ABSTRACT
Today, functional MRI (fMRI) is the most widely-used method for measuring activity across the entire human
brain. FMRI is used to infer ‘functional connectivity’, and most studies utilize coarse spatial resolution (~2 mm
isotropic) with which it is possible to detect interactions between brain areas at the centimeter scale. However,
this approach lacks the ability to estimate the directionality of neuronal communication flowing from one brain
area to another, and thus cannot decipher the underlying circuitry needed to investigate brain computation.
Meanwhile, the emerging field of laminar fMRI seeks to resolve activation patterns across cerebral cortical layers,
and has shown the potential to interrogate the directionality of these connections by probing correlations between
input and output layers of cortical areas. Yet even with the highest spatial resolutions available at 7 Tesla (0.8
mm isotropic), laminar fMRI data are marginally capable of isolating the activity of individual cortical layers and
are incapable of covering the entire brain with adequate temporal resolution. Here we propose to supplement
conventional whole-brain functional connectivity with an ultra-high spatial resolution (0.125 mm) interrogation of
cortical laminar connectivity. Our technology automatically places multiple independent 1D “linescan” fMRI
acquisitions normal to the cortical surface within functional ‘hubs’ identified in a prior conventional fMRI scan.
Linescan MRI is a classic method that acquires a “1D image”—i.e., a single line—enabling ultra-high spatial
resolution in the “in-line” direction down to ~100 μm. Since only one line is encoded, it also enables short
readouts and ultra-fast temporal resolution. Linescan MRI is well-suited to cortical layers, provided that the line
intersects the cortex exactly perpendicularly. Accurate manual prescription of one linescan at a given location in
human cerebral cortex is difficult with the MRI console’s user interface; prescribing several linescans across a
brain network is prohibitive. Also, linescans cannot be retrospectively corrected for motion. We will overcome
these challenges to enable concurrent linescan fMRI at multiple cortical locations to study communication along
feedforward and feedback pathways between cortical areas. We will also develop novel radiofrequency pulses
to sharpen the ‘line profiles’ to increase resolution and boost SNR. We will develop both novel gradient-echo
linescan fMRI to provide ultra-fast temporal resolution and spin-echo linescan fMRI to provide pure T2 contrast—
difficult to attain with conventional fMRI—for microvascular weighting and increased neuronal specificity. We will
apply our linescan fMRI in experiments designed to showcase its unique capabilities and advantages. We will
extend previous findings by measuring layer-specific interactions between left and right motor cortex, then
demonstrate, for the first time, how input layers and the cascade of information across visual cortex can be
inferred from the onset time of the layer-specific activation, and test a novel hypothesis about directed
communication within the Default Mode Network. The outcomes will be dissemination of data acquisition/analysis
technologies that expand the scope of what is possible with fMRI, and novel insights into human brain circuitry.

Public health relevance
PROJECT NARRATIVE All functional Magnetic Resonance Imaging (fMRI) methods in use today measure human brain activity by tracking the associated changes in blood flow, volume, and oxygenation, and recent evidence suggests that these hemodynamic changes are controlled at a fine enough scale to permit localizing neuronal activity to the individual layers of the cerebral cortex, which would enable investigations of brain circuitry. Unfortunately, most fMRI methods lack the imaging resolution to detect these hemodynamic responses within cortical layers, which have a thickness of only a few hundreds of micrometers. To address this, here we will develop new tools using “line-scan” imaging to enable human fMRI with extremely high resolution in just one direction, perpendicular to the cortical layers, along with several technical advancements to make these tools reliable and widely usable, and then apply them to several investigations seeking to map out brain circuitry in healthy volunteers.